Cancer Prevention and Control Research Program

ABSTRACT: CANCER PREVENTION AND CONTROL PROGRAM
The UNC Lineberger Cancer Prevention and Control Program focuses on the development, evaluation, and
dissemination of evidence-based interventions and policy approaches to improve cancer outcomes in North
Carolina and beyond. Our program is comprised of 56 program members and fosters strong collaborations
between faculty from the six schools; Schools of Medicine, Public Health, Nursing, Pharmacy, Media and
Journalism, and the College of Arts and Sciences and 28 departments.
The CPC program has four broad themes: (1) Implementing health promotion interventions to reduce cancer
risk factors; (2) Developing cancer communication strategies to improve cancer prevention and control; (3)
Improving quality of cancer care and long-term outcomes for cancer survivors; and (4) Studying patterns of
cancer care, screening, and prevention to inform interventions and policy initiatives that improve cancer
outcomes. Eliminating cancer health disparities is a cross-cutting theme of our program.
Highlights of our nationally recognized research by program investigators include: tobacco control policy
research on the design and efficacy of graphic cigarette warning labels that is guiding FDA policy; research on
sales and marketing of electronic cigarettes, including interventions to prevent adolescent e-cigarette use;
research on digital and mobile interventions for diet, obesity, physical activity, and symptom management with
particular focus on disadvantaged populations and cancer survivors; novel patient-reported outcomes studies
that inform national policy; and implementing interventions in our Catchment area of North Carolina focused on
eliminating disparities in access and outcomes.
The Program is led by Dr. Kurt M. Ribisl, a behavioral scientist, and Dr. Ethan Basch, a medical oncologist
and health services researcher. Program members are PIs of three NCI funded pre- and post-doctoral training
grants. The Program adds value in terms of integrative activities and opportunities for intra- and cross-program
collaboration; professional development and networking support for junior faculty CPC members; access to
shared resources such as the Communications for Health Applications and Interventions, Biostatistics, and
Patient-Reported Outcomes Core; as well as space, seminars, retreats, training, and education. Since our last
renewal, UNC Lineberger has benefited the Program through strong support for infrastructure, faculty
recruitments, extensive use of shared resources, and providing developmental funds as befits one of three
major UNC Lineberger strategic directions, “Optimizing Cancer Outcomes in North Carolina.” During the last
funding period, program members have published 1359 cancer-related articles, 26% were intra-programmatic
and 19% were inter-programmatic (38% collaborative). In 2019, our program members held grants totaling
$18.9M (direct cost) in cancer-relevant extramural funding, including $6.8M (direct costs) from the NCI and
$8.9M in other peer-reviewed funding.